Johns Hopkins University Trial Innovation Center

The Johns Hopkins University (JHU) Trial Innovation Center (TIC) is a well-established, highly functioning team
with a goal of dramatically improving the conduct, efficiency and impact of multisite randomized controlled trials.
The TIC includes experienced trial scientists, project managers, statisticians, and trial staff with external
collaborators from 5 research intensive CTSA Hubs. BIOS, a JHU trials research group, will operationally
convene this group and provide staff to execute version 2.0 of the Trial Innovation Network (TIN) program and
its specific tasks as previously and collaboratively determined by the TICs, RICs and NCATS. During TIN 1.0 our
joint expertise Developed and Demonstrated new methods for multicenter trials and provided these methods via
the TIN platform to individual CTSA Hub PIs wishing to perform multisite randomized trials. This proposal is
derived from our established track record of trial execution accomplishments and trial science innovations, which
will facilitate dissemination of these methods and specific trial tools towards the NCATS goal to speed
translational research. We identified needs not met in TIN 1.0 including: trial training of hub staff, training in
operations rather than strategy, preceptorship for Hub CCC/DCC capabilities, and need for up-to-date
operational methods/tools. In TIN 2.0 we will further Develop new trial tools and methods for testing their ease
of implementation at CTSA hubs, Demonstrate the effectiveness of this approach, and Disseminate broadly to
CTSA Hubs, by using case studies and didactics. We propose an integrated, coordinated, multi-stakeholder TIC
process to improve the efficiency and quality of multi-site trial initiation and subsequent execution by CTSA sites.
Our group of external collaborators will work as a sample of the larger CTSA-TIN consortium to develop Hub
implementation and dissemination approaches on both a case- and consortium-wide basis. The JHU TIC will
leverage operational activities in CTSA trials implementation to study novel operational innovations that improve
participant engagement, intervention adherence and measurement of trial endpoints. We will measure benefits
using explicit efficiency- and quality-focused metrics to test these innovations. The scientific purpose of our
team’s efforts will be to demonstrate that TIC innovations in trial design, execution, and evaluation can lead to
better trial performance, including faster start-up, faster completion, greater protocol compliance and more
precise endpoints. We will disseminate results of validated CTSA-TIN innovations produced from consortia trials
to CTSA Hub clinical trial teams and research trainees. We will collaborate with NCATS to utilize the platform
demonstrated in TIN 1.0 to engage and equip a multisite randomized clinical trial workforce through the CTSA
Hubs to perform trials faster and at a higher quality in TIN 2.0.

Public health relevance
The Johns Hopkins University (JHU) Trial Innovation Center (TIC) represents an established, high functioning team of multisite trial PIs, experienced trial scientists, project managers, statisticians, and trial staff, including external trialist collaborators from 5 CTSA Hubs, that will leverage operational services and trial science in CTSA trials to develop and study novel operational innovations that improve participant engagement, protocol compliance and measurement of trial endpoints. The team will demonstrate that TIC innovations in trial design, execution, and evaluation can lead to better trial performance, including faster start-up, faster completion, greater intervention adherence and more precise endpoints leading to enhanced efficiency and impact. The JHU TIC will build capacity by disseminating results of valid CTSA-TIN innovations tested within consortium trials to CTSA clinical trial teams and research trainees.